Characterizing the role of CSDE1 as a critical co-factor for VSV replication.

PROJECT SUMMARY
We have repeatedly observed that cells acquire the ability to escape from viral replication/lysis upon long-term
low-level exposure to Vesicular Stomatitis Virus (VSV). Whilst investigating the mechanisms associated with
escape, we showed that APOBEC3B is a major effector of mutational plasticity in cells which evade viral
replication/therapies including VSV. RNAseq of cells which escaped VSV identified ~300 coding mutations
with APOBEC3B signatures, some of which we hypothesized would directly affect the ability of the virus to
replicate within target cells. Of these mutations, a single C-T point mutation in the Cold Shock Domain
Containing E1 (CSDE1) gene (CSDE1C-T), which generates a mutant CSDE1 protein CSDE15P-S, was
expressed at high clonality in both human and murine cells, of different histological types, which became
resistant to VSV. These data show, for the first time to our knowledge, that CSDE1 plays a highly significant
role in replication of, and oncolysis by, VSV. We also observed that VSV can co-evolve to complement cellular
mutations such as CSDE1C-T. Thus, forced evolution of wild type VSV through CSDE15P-S cells allowed us to
track the emergence of a mutant virus VSV-IFNß-IGR P/MC-U. This virus contained a highly specific mutation
in the Intergenic region between the P and M genes of VSV (IGR P/MC-U) (located in the only perfect
consensus binding site for CSDE1 in the VSV genome) and completely rescued high level replication of virus
in cells expressing mutant CSDE15P-S. On the basis of these data, here we will test our overarching hypothesis
that CSDE1 is a critical mediator of the replication of VSV; that mutation in CSDE1, such as at CSDE1C-T,
allows for target cell escape from replication of VSV; and that VSV can evolve compensatory mutations to
recover replication fitness in CSDE1(C-T)-mutated cells. To test this hypothesis, we have formulated four
Specific Aims in which we will: (Aim 1) define how CSDE1 mediates replication of VSV, and how mutations in
CSDE1 are critically associated with escape from VSV; (Aim 2) understand how the IGR P/MC-U mutation in
VSV complements CSDE15P-S; (Aim 3) track the induction of the IGR P/MC-U mutation as the virus undergoes
strong selective pressures against its replication and identify the cellular anti-viral mutational pathways which
imprint mutational signatures onto VSV genomes; and (Aim 4) exploit our discovery of CSDE1 as a critical co-
factor for VSV replication to generate CSDE1-expressing VSV with enhanced efficacy as both vaccination and
oncolytic platforms. Overall, these studies will have significant impact in understanding VSV/host cell
interactions, in defining pathways by which viruses can usurp anti-viral mutagenic pathways to seed escape-
competent quasi species and will inform development of novel, improved VSV for vaccination and oncolysis.

Public health relevance
PROJECT NARRATIVE By screening cellular mutations induced by VSV infection which allow for escape from viral replication, we identified a cellular protein, CSDE1, as a major co-factor of VSV replication. Here, we will define how CSDE1 mediates replication of VSV, how compensatory mutations in the virus are induced to recover viral fitness in virus-resistant cells, and how we can exploit our discovery of CSDE1 as a critical co-factor for VSV replication to generate CSDE1-expressing VSV with enhanced efficacy as both vaccination and oncolytic platforms. Our studies will have significant impact in understanding VSV/host cell interactions, in defining pathways by which viruses can usurp anti-viral mutagenic pathways to seed escape-competent quasi species and will inform development of novel, improved VSV for vaccination and oncolysis.